Disease-modifying drugs for T2D through targeting the Unfolded Protein Response

Project Summary/Abstract
Type 2 diabetes (T2D) is a chronic degenerative cell disease characterized by hyperglycemia due to
progressive progressive loss of overworked pancreatic islet beta cells. Recent work from our laboratories has
shown that hyperactivation of the unfolded protein response (UPR) to ER stress in beta cells due to upstream
may be a critical early event in the development of T2D. We have developed and are refining novel small
molecule pharmacological reagents that allow us to manipulate critical components of the UPR—called KIRAs
that maintain desirable (adaptive) outputs of the UPR while quelling undesirable (maladaptive) outputs
including insulin resistance in peripheral tissues, consequently leading to apoptosis and diabetes. We show
that first generation versions of KIRAs we developed against a kinase/RNase target called IRE1α can
efficaciously prevent and even reverse diabetes in leptin deficient ob/ob mice. Here, we plan a medicinal
chemistry campaign using several strategies to optimize KIRAs on three scaffolds towards the clinic. In this
collaborative grant we will capitalize on the complementary expertise of the investigators to optimize these
KIRA lead molecules for potency, selectivity, drug-likeness (including oral bioavailability) and conduct critical
proof-of-concept studies using reductionist chemical genetic systems, ob/ob and HFD-fed mice, and human
islets, and perform key IND-enabling steps needed to advance these candidates further into the clinic for
eventually treating human patients with T2D.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes (T2D) is a chronic cell degenerative disease characterized by hyperglycemia due to progressive destruction of pancreatic β-cells due to these cells having to counter upstream insulin resistance (most often in obese states). The high secretory burden of these insulin-producing professional secretory cells predisposes them to high levels of endoplasmic reticulum (ER) stress, and recent work from our laboratories has shown that the activation of ER stress response pathways such as the unfolded protein response—UPR—may be an initial causal event in the development of T2D. In this collaborative grant we capitalize on our complementary expertise of the investigators to pharmacologically target the UPR by advancing new kinase inhibitors called KIRAs as new disease-modifying approaches for T2D.